Michigan Chemistry-Biology Interface Training Program

PROJECT SUMMARY/ABSTRACT
The University of Michigan proposes the renewal of a predoctoral Chemistry-Biology Interface
(CBI) Training Program, whose overarching training mission is to implement effective approaches
to training and mentoring for students working across the chemistry-biology continuum. Our core
objectives remain to 1) recruit and retain high quality and diverse trainees, 2) provide a unique
interdisciplinary training experience that adds value to training from the home graduate program,
and 3) provide mentorship and training strongly supporting successful Ph.D. degrees and life-
long productive careers in a broad range of research related settings. The CBI Training Program
faculty includes chemical biologists, synthetic organic and inorganic chemists, bioorganic
chemists, bioanalytical chemists, mechanistic enzymologists, spectroscopists, and structural
biologists from eight departments. From these departments and one free-standing graduate
program a diverse cohort of talented and promising second-year PhD students will be selected
and appointed for two years. A total of 10 trainees per year for five years are requested.
The CBI didactic component includes two core courses in Chemical Biology and a seminar.
This curriculum also includes a novel student sabbatical to be completed in an external, broadly
defined, research-related environment. Based on former trainee feedback on its outsized
influence on their careers, this experiential sabbatical program is one of the most unique and
impactful training opportunities available to University of Michigan CBI trainees. Additional CBI
career exploration and professional development occur via an annual symposium, invited career
and scientific speakers, and regular trainee meetings. Interactions at these latter monthly
meetings and close attention one-on-one mentoring promote a supportive and inclusive CBI
trainee community. Research opportunities for CBI trainees are widely varied across chemical
biology and include access to the most sophisticated techniques and cutting-edge instrumentation
in modern chemical biology research. Both research and classroom training emphasize
responsible conduct in research and strategies for conducting reproducible research with the
highest standards of scientific rigor. The ability to positively impact trainees is supported by an
emphasis on maintaining a diverse and inclusive training environment, expanding trainee
exposure to non-traditional careers, increasing mentor training, and extending career support
beyond the PhD period. Overall, the rationale for this integrated program is to provide the
supplemental interdisciplinary training, professional skills, and the career savvy for CBI trainees
to successfully advance chemical biology solutions to biomedical research problems.

Public health relevance
PROJECT NARRATIVE This program proposes an integrated, effective training plan to generate a diverse community of scientists who can work effectively across traditional divides in chemistry and biology to solve important biomedical problems.